Methods-and-Mentors Experience in Research-Data Science Skills in Rehabilitation and Whole Health for Aging Veterans (SUMMERDSSRWHAV)

The Veteran's Administration (VA) Maryland Health Care System (VAMHCS) Summer Research
Program (SRP), called the SUMMERDSSRWHAV Program, will advance three complementary priorities: to put VA
data to work for Veterans, address underrepresentation in the research workforce, and support
interprofessional collaboration and community. The next generation of VA healthcare providers and
researchers will care for over nine million Veterans and make scientific breakthroughs by mining one of the
VA's most critical resources—data. These data, utilized by a diverse workforce that is reflective of the
population it serves, have the potential to transform clinical care and improve the health and well-being of
Veterans, their families, caregivers, and survivors. Developing this diverse and inclusive scientific workforce is
a mission-critical objective. Therefore, the VAMHCS SUMMERDSSRWHAV Program aims to increase trainee
competence in the ethical conduct of research, proficiency, and confidence in managing various aspects of
data-driven science (from research question conception to project presentation), and core competency in the
areas of Roles and Responsibilities, Ethics and Values, Communication, and Teamwork as defined by the
Interprofessional Education Collaborative (IPEC).
For eight weeks, program participants will engage with an empowering curriculum that introduces
geriatric, rehabilitative, and whole health principles woven together by core skills in research methods and data
science. All student participants will be paired with scientific mentors and data science co-mentors to foster a
culture of innovative scientific expression, professional identity, and personal confidence. Site visits across the
Veterans Integrated Services Network 5 (VISN 5), and with academic affiliates, will enable participants to
palpably connect healthcare research with its impact on patient outcomes and service delivery, and to visualize
the diversity of roles they might adopt in future careers. The SUMMERDSSRWHAV Program will also stimulate
relationship building and collaborative problem solving through unique program features including our
partnership with another SRP and a “Data Science Hack-a-Thon.” Program learning outcomes and impact will
be measured through both formative and summative evaluation processes. Formative assessments will help
improve the project components, while summative assessments will examine the achievement of project
objectives including proficiency in Interprofessional Education Collaborative (IPEC) competencies.
Our program strategy is to expose students from underserved populations, who may have previously
faced barriers to science, technology, engineering, and mathematics (STEM) education and research
opportunities, to critical quantitative skills; while placing trainees in a strong supportive environment featuring
data management support, tutorial support, and strong co-mentorship teams. Our interprofessional leadership
team consists of experienced clinicians and researchers from diverse backgrounds, some of whom have faced
similar barriers in their own careers. Together these experiences will help mentees see the impact data
science can have on research, the health of Veterans, and help them gain confidence and a sense of
belonging in the STEM and healthcare fields; while also strengthening and building capacity at VAMHCS, our
academic affiliates, and with other SRP partners.

Public health relevance
The goal of our Summer Research Proposal (SRP), strategically located in the VA Maryland Healthcare System (VAMHCS)'s Geriatric Research, Education, and Clinical Center (GRECC) in Baltimore City, is to develop a new generation of diverse, young scientists and support quality scientific research that will improve Veteran health and well-being. Our annual eight-week program will pool resources by working with groups across the VAMHCS, GRECC, and academic affiliates to build high-demand data science skills among a diverse and inclusive group of healthcare students. An interdisciplinary team of experienced science educators and mentors, led by Drs. Conroy and Hogans, will deliver a tailored curriculum within the context of whole health, aging science, and rehabilitation. Learning will extend beyond the VAMHCS through our unique collaboration with the VA Caribbean SRP bringing additional opportunities to our trainees while fostering a culture of innovation and professionalism in putting VA data to work for Veterans, their families, and caregivers.